CD103 engagement regulates intestinal IEL effector function

PROJECT SUMMARY.
Mucosal surveillance of the intestinal barrier by tissue-resident lymphocytes is critical for preventing the
invasion of enteric pathogens and a necessary component of protective immunity. A single layer of epithelial
cells lines the intestinal tract and provides a physical barrier between microbes, dietary antigens, toxins and
the rest of the tissue. Therefore, the reactivation of lymphocytes at the intestinal barrier must be tightly
regulated, as too robust of a response could result in destruction of the epithelium leading to microbial
translocation and eventual autoimmunity, as observed in inflammatory bowel disease and celiac disease.
Tissue-resident intraepithelial lymphocytes (IELs) in the intestine provide a first line of defense against invading
microorganisms and the intestinal IEL compartment is composed of what has been termed induced and natural
IELs. Induced IELs are CD8ab+ TCRab+ tissue resident memory (Trm IELs) cells that are recruited to the
epithelial compartment following antigen exposure. In contrast, natural IELs are not MHC-restricted and include
CD8aa+ IELs expressing TCRgd (gd IELs). gd and Trm IELs represent the majority of the lymphocytes in the
intestinal epithelium and could serve both protective and pathogenic roles, yet mechanisms regulating their
activation during infection in vivo remain largely unexplored. CD103 (aEb7 integrin) is expressed by the majority
of gd and Trm IELs located in the intestine and at other barrier sites. CD103 binds to epithelial E-cadherin and
plays an important role in the recruitment and maintenance of tissue lymphocytes. However, the contribution of
CD103 to IEL functionality within the intestine during infection has not been addressed. Successful completion
of the proposed aims will provide fundamental insight into the molecular mechanisms by which CD103 ligation
to E-cadherin promotes (1) the motility and activation of Trm and (2) gd IELs and the role of CD103 in
promoting protective responses to enteric infection. These studies will uncover novel mechanisms by which
direct interaction between IELs and epithelial cells contribute to host immunity and further define the molecular
cues regulating sentinel lymphocyte populations in mucosal homeostasis and infection.

Public health relevance
PROJECT NARRATIVE. The proposed research is relevant to public health because it will elucidate the fundamental biological processes by which the immune system contributes to maintenance of the mucosal barrier. This essential knowledge is required to understand mucosal surveillance during intestinal homeostasis and in response to pathogen infection. This work will therefore directly support the overall NIH mission of developing knowledge that will help reduce the burden of human disease and promote the NIAID goal of preventing infectious and immunologic diseases.